Sensitivity enhanced MRI imaging of receptor binding in breast cancer

Cancer remains one of the leading causes of death in the industrialized world. In recent years, there has been a resurgence of interest in tumor lactate metabolism since lactate has been associated with metastases and poor prognosis in cancer patients. Recent discoveries have identified that the cell surface lactate receptor HCA1 is associated with tumorigenesis and metastasis and thus an attractive imaging target and possible therapeutic target. However, because lactate exhibits low affinity and a fast turnover rate, current in vivo molecular imaging techniques are not well suited to image these types of targets. We have developed a novel MRI based approach for detecting the low affinity binding of natural (no chemical modification) substrates to molecular targets and a unique molecular pump scheme that enhances the sensitivity two to three orders of magnitude thus making this technology applicable for in vivo studies. Importantly, this method can be implemented on standard MRI hardware and thus rapidly translated to the clinic. We propose developing, optimizing, and validating this approach for imaging the binding of lactate to HCA1 receptors in breast cancer. In AIM 1, we will validate the specificity of detecting lactate-HCA1 binding in vitro using (i) perfused breast cancer cells that express different levels of the HCA1 receptor, and (ii) MRI pulse sequence optimization. In AIM 2, we will validate the specific binding of lactate to breast cancer cells in vivo. We will further probe lactate binding using the infusion of L-lactate or D-glucose (metabolized to lactate), both FDA approved for iv use in humans. These aims are expected to result in a MRI method for imaging the binding of low-affinity ligands to a cell target. Due to the nature of the labelling approaches, these MRI methods will be highly tunable to a broad range of other substrates-target pairs.

Public health relevance
Narrative The development of imaging methods for early diagnosis and monitoring of targeted therapies is vital in ensuring positive outcomes for cancer patients. We propose to develop a new method to image the dynamic binding of ligands to cell surface targets in vivo using standard MRI hardware. This approach will result in a new tool for non-invasively monitoring the delivery of natural (no chemical modification) substrates to novel targets in cancer.